Computational volumetric one-photon voltage imaging in rodents

Project Summary
To understand how the brain develops and accomplishes its unique computational and cognitive capabilities
through the dynamics of three-dimensional networks of neurons remains a key goal of contemporary
neuroscience. To inform accurate modeling of network dynamics, tools will be indispensable that enable
recording of neuronal activity at both, the temporal scale at which neuronal communication and computation is
performed, and a spatial scale that encompasses the ensemble of neurons participating in a given function.
Recently, increasingly efficient genetically encoded voltage indicators (GEVIs) have been developed that allow
optical readout of electrical neuronal activity at a millisecond timescale. However, recording of GEVI activity has
remained limited to small fields-of-view and few axial planes, either due to low signal and speed achievable in
scanning multiphoton methods or due to the low signal-to-background ratio that hampers existing one-photon
modalities. To develop optical recording techniques capable of capturing the full electrical dynamics of large
ensembles of neurons therefore remains an unmet need.
This project aims to address this need by designing and demonstrating a novel ultra-high-speed volumetric
imaging system capable of capturing the full dynamics of genetically encoded voltage indicators from thousands
of neurons in the cortex and hippocampus of awake, behaving rodents. This will be achieved through a
combination of structured one-photon excitation with advanced light field detection. The proposed technique
will achieve a temporal resolution sufficient to capture the timing of single action potentials from thousands of
neurons. The voltage dynamics of active neurons will be extracted and demixed from background and crosstalk
by an advanced machine learning algorithm that exploits the presence of unscattered and weakly scattered light
in the targeted depth range.
The proposed approach is designed to deliver a time resolution approaching electrical recordings while also
determining the 3D positions of all active neurons in a volume, in a manner that is immediately parallelizable to
cover larger lateral areas at minimal invasiveness. If successful, this project will therefore contribute to enabling
optical electrophysiology at the level of entire neuronal systems.
1

Public health relevance
Project Narrative The brain processes information through the collective activity of large networks of neurons that integrate incoming stimuli and respond by sending precisely timed electrical impulses towards their neighbors. Here we propose to develop a novel computational microscopy method designed to capture the signals emitted from fluorescent voltage-sensing reporter proteins across large volumes of mammalian brain tissue and thus measure electrical neuronal activity from thousands of individual neurons. This unprecedented recording capacity will enable precision studies of how neuronal network activity works on a fundamental level and will allow insights into how it is altered in pathological disorders of the human brain. 1